University of Utah Genetics Training Program

PROJECT SUMMARY/ABSTRACT
The proposed Genetics Training Program (UGTP) at the University of Utah (UofU) will provide in-depth training
in Genetics for a diverse group of 12 predoctoral students, arming them with scientific and professional
knowledge and skills needed to conduct independent and rigorous research and become leaders within the
biomedical research workforce. The U of U has a well-established, successful graduate training effort in
genetics research, including a long-running Genetics T32 (45 years). The proposed new UGTP is an intensive
two-year program of training in quantitative analysis, rigorous and transparent experimental practices,
professional skills, the ethical practice of science, mentorship, and equity/inclusivity. These foundational
objectives support the development of future multi-dimensional leaders and mentors in genetics research.
The UGTP engages trainees at a formative stage of their career, in their 2nd and 3rd years of graduate school.
Benefits of the program extend both before and after the intensive two-year training period. Completion of a
pre-requisite first year graduate curriculum covering basic transmission genetics, ethical practices in research,
critical thinking, hypothesis development, and understanding of rigor and reproducibility is required for the
UGTP. Students who successfully pass a Capstone Exam administered at the end of Year 1, assessing trainee
potential for independent research and rigor in scientific analysis and experimental thinking, are eligible for the
UGTP. Each year about 12% of the approximately 50 TGE students are selected to become trainees.
Trainees convene year-round in a suite of enriching activities. The central feature of the Training Program is a
seminar course led by the PDs, limited to trainees, in which the students i) present research, critically evaluate
progress, and discuss scientific best practices; undertake continued training in ii) RCR and iii) rigor,
transparency, and reproducibility; participate in workshops on iv) professional development, v) mentoring; and
vi) recognizing and responding to biased behaviors. Trainees present their research progress annually before
the entire UofU Genetics community and select and host visiting genetics speakers throughout the year. Three
advanced courses in quantitative and genetics analyses provide a breadth of training in the field of Genetics.
The UGTP provides continuous mentorship in research and professional development: trainees develop IDPs
with the Program Directors, adopt an extra mentor from the UGTP Steering Committee who provides guidance
and communication with the UGTP, and participate in events aimed at career development and building an
inclusive community. Following two years of UGTP-supported research with one of 61 UGTP faculty, trainees
remain engaged through a novel initiative of near-peer mentorship, a program feature that supports the
scientific and cultural development and mentoring skills of our trainees. The UGTP engages the entire UofU
genetics community year-round through external speakers, Concepts in Genetics Seminars, and an Annual
Retreat featuring trainee talks, plenary speakers, and poster presentations from the UofU genetics community.

Public health relevance
NARRATIVE Genetics is the study of how the information governing traits of an organism is decoded, how this information is stably passed on between generations, and how variant traits, including altered appearance, behaviors, birth defects, or disease states, arise. Studying the functions of genes, the control of their expression, and the effects of genetic variation give practical insights into how normal development and health are established and maintained, and how changes in gene function and expression contribute to congenital defects, aging, the origins of cancer, and the basis of many diseases. The goal of this Genetics Training Program is to give a diverse set of outstanding predoctoral researchers a broad education in genetics, intensive training in the process of performing and evaluating research in a rigorous and ethical manner, and mentorship and support of their development as productive members of society who apply their training in ethics, inclusiveness, and genetics during their careers.